PROJECT 2 – CHEMICAL MODULATION OF DNA DEAMINASES IN CANCER

PROJECT 2 – CHEMICAL BIOLOGY OF DNA DEAMINASES IN CANCER
ABSTRACT
APOBEC3 enzymes are single-stranded DNA cytosine-to-uracil deaminases that normally protect cells from
viral infections. However, APOBEC3A (A3A) and APOBEC3B (A3B) have been implicated in causing cancer
mutations that drive tumor evolution and contribute to the development of drug resistance and, ultimately, therapy
failure. Our Program’s overarching and unifying hypothesis is that A3A and/or A3B inhibition will prevent a large
proportion of new mutations, thereby improving the durability of current treatments and resulting in better overall
outcomes. To address this hypothesis our Program is focused on understanding the structural biology of DNA
deaminases in cancer (Project 1); characterizing the biology of DNA deaminases in cancer (Project 3); and
developing chemical inhibitors and degraders of A3A and A3B deaminases (here). These highly integrated
projects are supported by service cores for administration (Core A), proteins and assays (Core B), and
computational chemistry, biophysics, and bioinformatics (Core C). Project 2 – Chemical Biology of DNA
Deaminases in Cancer will be the center of chemical innovation for the Program by, in Aim 1, exploiting our
expertise in nucleic acid-A3 molecular recognition to develop nucleic acid-based inhibitors of A3A and A3B
deaminase activity and nucleic acid-based chemical degraders of A3A and A3B. In Aim 2, we will use A3A- and
A3B-binding small molecules, already identified from high-throughput screening, computational designs,
fragment-based inhibitor testing, mass spectrometry-based assays, and rationally designed peptidomimetics to
develop potent, cell-permeable, and non-cytotoxic A3A and A3B ligands. Lead compounds from these series will
be optimized by collaborative Program activities and further developed into A3A/B inhibitors and degraders.
Taken together, Project 2 will provide new insights into the chemical biology of APOBEC enzymes and contribute
to the achievement of our overall research objectives including our long-term goal of blocking the evolution of
A3-positive cancer cells.

Public health relevance
PROJECT 2 – CHEMICAL BIOLOGY OF DNA DEAMINASES IN CANCER NARRATIVE APOBEC3A (A3A) and APOBEC3B (A3B) are DNA-mutating enzymes frequently activated in cancer cells, which contribute to tumor evolution including mutations that cause drug resistance. The long-term goal of this Program is to therapeutically inhibit A3A and A3B and thereby help to suppress detrimental outcomes such as drug resistance and metastasis. Project 2 – Chemical Biology of DNA Deaminases in Cancer will contribute to this overarching goal by developing novel A3A and A3B inhibitors and degraders (nucleic acids, small molecules, and peptidomimetics) that will serve as mechanistic probes of enzyme function and provide lead compounds for drug development.